Detection and elimination of drug tolerant persister cells in small cell lung cancer

Project Summary
Small cell lung cancer (SCLC) is a highly aggressive, neuroendocrine malignancy that follows predictable and
dispiriting clinical course. Initially, SCLC patients are uniformly treated with combination chemo-immunotherapy
and, for most patients, this approach initially appears successful with dramatic improvement in clinical symptoms
and tumor burden. However, just as rapidly as the tumor recedes, it invariably recurs and, upon recurrence,
exhibits more molecularly heterogeneous and drug-resistant biology. This narrowly missed opportunity in which
SCLC is nearly vanquished only to re-emerge even stronger highlights the urgent, unmet need to identify and
target those drug tolerant persister cells (DTPCs) responsible for this malignant sleight of hand. This need is
explicitly articulated by the National Cancer Institute’s Scientific Framework for Small Cell Lung Cancer as one
of five initiatives within the Recalcitrant Cancer Act - “investigate the mechanisms underlying both the high initial
rate of response to primary SCLC therapy and the rapid emergence of drug and radiation resistance following
completion of treatment”. To address this need, we have assembled an unparalleled repository of SCLC patient
samples and patient-derived models from all relevant clinical timepoints, as well as a multi-disciplinary team with
scientific, clinical, translational, and computational expertise in SCLC. Our preliminary data in SCLC models
validate not only the existence of these long-hypothesized DTPCs, but also the feasibility of their procurement
for molecular and therapeutic analyses. Further, we have demonstrated the relapsed SCLC state is enriched for,
though not solely composed of, putative DTPCs with unique therapeutic vulnerabilities. Based on these data, we
hypothesize that we can technically enrich for and select DTPCs from SCLC genetically-engineered and patient-
derived models, as well as patient samples, and that their cell surface proteome represents an actionable
vulnerability for their elimination. To address these hypotheses, we propose the following Aims: in Aim 1, we will
collect DTPCs and molecularly characterize DTPCs in SCLC models treated with standard platinum-based
chemotherapy to then track their emergence and trajectory in models and patient samples. In Aim 2, we will
characterize the ability of the newest class of just-approved SCLC agents – a bi-specific T-cell engager (BiTE)
against Delta-like ligand 3 (DLL3) – to shape, or even eliminate, the post-platinum DTPC population. Lastly, in
Aim 3, we will develop preclinical antibody-based therapeutics, like antibody-drug conjugates (ADCs) or chimeric
antigen receptor (CAR) T-cells that specifically target surface proteins enriched in those DTPCs that survive both
platinum-based chemotherapy and DLL3 BiTEs. Together, these aims will comprehensively characterize and
validate the DTPC landscape following state-of-the-art SCLC treatments and offer clear candidates for their
elimination in future clinical trials.

Public health relevance
Project Narrative Despite frequent initial responses to chemo-immunotherapy, small cell lung cancer (SCLC) patients virtually never experience durable disease control, instead inevitably, and often rapidly, relapsing after this initial response. This clinical course necessitates that some SCLC cells – termed drug tolerant persister cells (DTPCs) - must survive the otherwise effective chemo- immunotherapy and re-initiate a highly recalcitrant relapsed tumor state. We propose that DTPCs can be enriched and selected for DTPC-specific molecular analyses, which, in turn, may guide DTPC-specific therapeutic development to eliminate this rare but highly consequential population.